Zero Suicide Implementation and Evaluation in Outpatient Mental Health Clinics

PROJECT SUMMARY
The proposed project is a renewal of our currently funded grant, # R01 MH112139 “Zero Suicide Implementation
and Evaluation in Outpatient Mental Health Clinics,” a large-scale project implementing the Zero Suicide model
of evidence-based suicide prevention practices in 165 outpatient behavioral health clinics in New York State.
Despite successful implementation of suicide screening and safety planning in our current project, treatment
engagement and retention of suicidal clients in a 90-day outpatient suicide care protocol was much less
successful. Approximately 36% of clients enrolled in the protocol did not return after intake, fewer than 30% of
clients received >6 sessions, and only 2% completed the recommended 12 weekly sessions. Thus, attention to
implementation of effective engagement and retention strategies is crucial to maximize effectiveness of
evidence-based suicide prevention. We plan to accomplish this by testing a novel implementation strategy that
incorporates individuals with suicide-related lived experience. This proposal builds on the infrastructure and
collaborative network developed in our current project and will target the implementation outcome of treatment
engagement and retention of clients at high suicide risk. This project continues collaboration with the NYS Office
of Mental Health and benefits from the State's existing administrative database infrastructure, including
mandated reporting of suicide attempts and deaths for individuals in care and client- and agency-level data on
treatment attendance, hospitalizations, and emergency department visits. Using a stepped-wedge, type III hybrid
effectiveness-implementation design in 12 agencies that participated in our current project, we will compare
standard implementation with a novel implementation strategy incorporating the voice of lived experience to
improve retention of at-risk suicidal clients. In the Peer Suicide Prevention Specialist Implementation (PSPSI)
condition, individuals with lived experience of suicidality will be active collaborators in the development and
delivery of clinical trainings and learning collaboratives and will work with primary clinicians to implement two
evidence-based strategies for improved client retention: structured phone outreach (SPO) and shared decision-
making (SDM). Our work will be guided by the EPIS (Exploration, Preparation, Implementation, and Sustainment)
framework. Aim 1 will compare standard implementation with PSPSI on rates of return after the first visit, session
attendance during a 90-day high risk protocol, and client outcomes (suicide attempts, inpatient hospitalizations,
and emergency department visits). Aim 2 will compare systems-, provider-, and client-level factors affecting
successful implementation between standard and PSPSI conditions using mixed qualitative-quantitative
approaches. Results will inform broader national implementation to enhance client retention in outpatient care
by including peers in suicide prevention interventions and thereby reduce loss of life to suicide.

Public health relevance
PROJECT NARRATIVE Suicidal individuals are difficult to engage and retain in outpatient behavioral health care, but serious negative consequences can result from treatment disengagement. In our current project, suicide screening and safety planning were successfully implemented in outpatient behavioral health settings but treatment engagement and retention of at-risk clients was problematic, with a significant number not returning for a second session and only a small % receiving the recommended dose of treatment. Recently, there has been increased focus on the importance of including individuals with lived experience in preventing suicide and our proposed renewal focuses on a novel implementation strategy incorporating the voice of lived experience to improve adoption of evidence- based treatment engagement strategies (structured phone outreach and shared decision-making) and client engagement, with the goal of guiding widespread implementation on incorporating peer specialists in the application of evidence-based engagement practices for suicide prevention in outpatient behavioral health settings.